Mechanisms of Papillomavirus Tumor Regression by MEK Signaling Inhibition

Project Summary
Human papillomaviruses (HPVs) are highly transmissible causative agents of benign and malignant tumors/
neoplasia in squamous epithelium. Despite prophylactic vaccines that prevent infection by up to nine HPV geno-
types that cause genital warts, respiratory papillomas, pre-cancerous lesions, and malignancies, millions of
unvaccinated people and those with existing infections will develop HPV-related diseases for at least
the next two decades. Treatments for HPV-associated diseases, precancers, and cancers have not been
significantly improved for decades; current therapies lack HPV specificity, have high recurrence rates, and
pose risk of long-term morbidities and reduced quality of life. To date, there are no effective antiviral HPV
therapies and no cure for HPV infections. Papillomavirus (PV) disease is primarily driven by PV early proteins,
E6 and E7. We reported that the cellular MEK/ERK signaling pathway is a critical regulator of HPV oncogene
expression and showed that MEK inhibitors (MEKi’s) profoundly suppress HPV E6 and E7 transcription
and neoplastic phenotypes in vitro; a systemically delivered MEKi, trametinib, also leads to tumor
regression in a mouse PV type 1 (MmuPV1) infection-induced model of HPV disease. However, the
mechanisms of MEKi-induced tumor regression are unknown. Our central hypothesis is that MEK inhibition
reduces MmuPV1 E6/E7 transcription leading to diminished keratinocyte (KC) proliferation and restored intrinsic
immune signaling to activate innate immunocytes and promote tumor regression. Preliminary data support the
rationale and feasibility of our approaches. Herein, we will leverage complementary unbiased tissue-based
single-cell and spatial transcriptomics coupled to targeted tissue-based approaches quantified using objective
morphometric digital pathology. Functional assays will be used to validate key findings. In Aim 1 we will ascertain
how MEK inhibition alters intrinsic KC antiviral responses in MmuPV1-infected mouse tumors and HPV-infected
rafts. We hypothesize that MEK inhibition coupled to reduced E6/E7 expression leads to restored intrinsic KC
immune signaling leading to tumor recruitment of cytotoxic innate immune. In Aim 2 we will define the role of
innate immune cells in MmuPV1 tumor growth and MEKi-induced tumor regression. We hypothesize that
recruited innate immune cells will display cytotoxic and/or phagocytic activities. In Aim 3 we will determine the
extent to which KC demise contributes to MEKi-induced tumor regression. We hypothesize that reduced E6/E7
expression leads to tumor KC apoptosis, and/or terminal differentiation. We envision both reduced KC expansion
and innate cell cytotoxicity contribute to MEKi-mediated tumor regression. Defining the contribution of MEKi-
induced antiviral effects to decreased KC proliferation and cytotoxicity in tumor regression is likely to reveal
additional targets for PV tumor treatment and potential biomarkers to assess in future clinical HPV studies; we
will increase our fundamental understanding of MEK signaling control of E6/E7 expression and innate immune
dysregulation in PV infections.

Public health relevance
Public Health Relevance/Project Narrative Human papillomaviruses (HPVs) are highly transmissible causative agents of benign and malignant tumors in mucosal and cutaneous squamous epithelium and pose significant health and economic burdens in the US and worldwide. Building on our finding that the inhibition of cellular MEK signaling suppresses papillomavirus early gene transcription and suppress established tumors in mice, we plan determine how the MEK inhibitors promote tumor regression. Successful completion of this work will fill critical gaps in our understanding of how papillomavirus infections are controlled by the innate immune system and reveal additional targets that can help us to treat papillomavirus diseases in humans.